Genetic circuitry governing heart growth and repair

Project Summary/Abstract
Current available clinical treatments greatly reduced the acute mortality of myocardial infarction. However, lost
cardiomyocytes during myocardial injury still cannot be replenished, leading to a steady increase of heart
failure patients. In contrast, adult zebrafish and newborn mammals are capable of robust cardiac regeneration.
This process has been shown to rely on proliferation of preexisting cardiomyocytes after injury. In rodents,
such an ability is lost within the first week after birth when the majority of cardiomyocytes undergo permanent
cell-cycle arrest. However, the physiological triggers of this transition remain largely unknown. Our recently
published work suggests that activation of thermogenic pathways during the acquisition of endothermy in
ontogeny and phylogeny may cause a loss of cardiomyocyte proliferative and regenerative capacity (Hirose et
al., 2019 Science). Following this direction, we discover that increases of neurohormonal activities associated
with postnatal thermogenesis drive cardiomyocyte cell-cycle exit, at least in part by turning on B cell lymphoma
6 (Bcl6), a transcription factor previously unappreciated in the heart field. Moreover, Bcl6 is also identified in
our RNA-seq analysis of all 1179 annotated mouse transcription factors as one of the top candidates that may
induce postnatal loss of cardiac regenerative potential. Intriguingly, cardiac expression of Bcl6 increases 19
folds after birth in mice but not in naked mole-rats (Heterocephalus glaber), a poikilothermic rodent. The
function of Bcl6 in cardiomyocytes have never been reported. Our preliminary data show that cardiomyocyte-
specific deletion of Bcl6 in mice leads to enhanced cardiomyogenesis both in heart growth and after ischemic
injury. We further identify a putative direct target gene of Bcl6, and demonstrate its major contribution to the
phenotypes through genetic rescue experiments in mice. Based on these results, this grant proposal will apply
a novel method that integrates whole-heart clearing, immunostaining and volume imaging by light-sheet
microscopy to accurately assess the total cardiomyocyte number, and exploit mouse genetic models to
elucidate the functions of Bcl6 and its downstream target in cardiomyocyte cell-cycle control during postnatal
heart growth and adult myocardial injury repair. The regulation of Bcl6 in ontogeny and its expression in
phylogeny will be further investigated to understand whether and how its expression increases in parallel with
the development and evolution of endothermy. Altogether, this work will yield significant knowledge about the
physiological brake of cardiac regeneration, and may offer novel treatment strategies to enhance heart
regenerative repair in adult mammals.

Public health relevance
Project Narrative This study aims to reveal the physiological triggers of cardiac regenerative potential loss during postnatal growth. This will provide novel insights into organ regeneration, possibly suggesting new targets and strategies to treat heart failure.